Aversive midbrain glutamatergic regulation of the locus coeruleus during opioid withdrawal

Fentanyl and other synthetic opioids are killing thousands of Americans each year. The overall goal of this
research is to better understand the role of the primary central noradrenergic system in fentanyl withdrawal. We
have known for decades that increased locus coeruleus-noradrenergic (LC-NE) system activity is critically
involved in both stress-induced increases negative affect and is potently modulated by withdrawal from opioids.
However, there is extensive, long-term controversy over the contribution of the LC-NE system to opioid
withdrawal-related behaviors. Critically, opioid withdrawal increases glutamate efflux into the locus coeruleus.
This fundamental feature of opioid withdrawal was identified and rigorously studied for many years, generating
potential therapeutic interventions that never reached the clinic. Study on this topic went largely quiet after lesions
studies indicated an intact LC-NE system was not necessary for the withdrawal-induced place aversion or
somatic signs of withdrawal. Despite these important findings, relatively little is known about afferent
glutamatergic regulation of LC-NE neurons in opioid withdrawal-induced negative affect. We will determine
whether a newly identified midbrain glutamatergic input to LC-NE neurons contributes to negative affective
behaviors associated with opioid withdrawal. We have now identified a largely unstudied afferent projection to
the LC from excitatory neurons in the ventral tegmental area (VTA), a region critical for processing reward and
motivation. While projections from these glutamatergic VTA neurons to the nucleus accumbens and lateral
habenula have opposing valences on aversion in mouse models, we hypothesize that VTA glutamate projections
to the LC-NE system produce negative affect and will be modulated by opioid withdrawal. Our preliminary
electrophysiology data suggests that this glutamatergic input to the LC amplifies other sources of glutamate. In
this proposal, we begin by seeking to determine whether withdrawal from fentanyl selectively modifies this
excitatory input the LC compared to other well-established excitatory inputs. Here, we will use brain slice
electrophysiology and in vivo microdialysis to test the hypothesis that excitatory VTA-LC activity is selectively
enhanced in opioid withdrawal. In the second aim, we will conduct behavioral studies modulating this excitatory
VTA-LC projection to determine whether it is needed for natural avoidance behaviors that guide actions away
from risk. Our preliminary data shows these behaviors that are amplified following fentanyl withdrawal. Together
these experiments will generate previously unattainable information about fentanyl-induced plasticity in VTA
glutamate inputs to LC-NE neurons and the negative affective behaviors these neurons generate. These studies
will clarify function of the excitatory VTA-LC projection by determining 1) whether fentanyl withdrawal alters their
input to the LC-NE system and 2) their role in fentanyl withdrawal-induced avoidance behaviors. This information
will be critical for translational research targeting noradrenergic and/or glutamate systems in the treatment of
opioid withdrawal and related neuropsychiatric disorders.

Public health relevance
Project Narrative Withdrawal from persistent opioid use causes an intense negative emotional state, but we do not fully understand the brain systems involved in this response. Prior work identified increased excitatory transmission into a brain region known for producing stress-induced anxiety. The goal of this proposal is to better understand how fentanyl withdrawal modifies this excitatory brain system to drive negative emotional states.